Novel CART Cells for Treating AML

Project Summary
Chemotherapy resistance remains a major barrier to successful treatment of patients with acute myeloid
leukemia (AML), contributing to high rates of relapse and mortality. Development of more effective treatments
for AML is imperative, particularly therapies with alternative mechanisms of action to circumvent
chemoresistance. Adoptive cellular immunotherapy using CD19-targeting chimeric antigen receptor (CAR)-
expressing T cells has drastically improved the treatment of patients with multiply relapsed/refractory B-cell
lymphoblastic leukemia (B-ALL) and lymphoma and was approved by the FDA. However, successful translation
of AML immunotherapies has lagged behind and remains a significant unmet medical need. To date, CAR T
cells targeting CD33 or CD123 for AML have shown potent preclinical anti-AML activity, but also induced severe
myelotoxicity via on target/off tumor damage to hematopoietic stem cells (HSCs). We have developed an
innovative system to isolate single-domain nanobodies (Nb) that preferentially bind AML cells and enable
cognate CAR T cells to kill the cancer cells. One of these nanobodies, Nb157, specifically binds to the cell surface
protein CD13 (aminopeptidase N), which is often upregulated in adult AML specimens and leukemia stem cells
(LSCs). In preliminary studies, we demonstrated that Nb157/CD13 CAR T cells (CD13CARTs) potently
eradicated AML cells in preclinical animal models. TIM-3, an inhibitory receptor of certain immune cells, is
upregulated in AML blast cells and LSCs, but not expressed in human HSCs. Thus, we generated the 1st
generation bispecific and split CD13/TIM-3 CARTs (1st G bCARTs) and demonstrated that the bCARTs potently
eradicated AML cells in preclinical animal models, with significantly reduced toxicity to HSCs. To further improve
the safety profile of the bCARTs, the 2nd generation bCARTs were generated and they did not induce obvious
toxicity to HSCs in our ex vivo analysis. We hypothesize that further development of the bispecific or inducible
bispecific CARTs can eradicate AML in patient-derived xenograft (PDX) models with little or tolerable off-tumor
toxicity. Three specific aims are proposed to test this hypothesis. Aim 1 will evaluate the 2nd generation bispecific
CD13/TIM-3CARTs (bCARTs) in maximizing selective AML killing. Aim 2 will investigate efficacy and specificity
of inducible CD13/TIM-3CARTs (ibCARTs) in killing AML cells. Aim 3 will develop bispecific CLL-1/TIM-3
bCARTs to selectively killing AML cells. Results obtained from these studies are imminently translatable to the
clinic in the near future for patients with relapsed/refractory AML.

Public health relevance
Project narrative Acute myeloid leukemia (AML) is highly aggressive, and over 70% of patients with AML eventually become refractory to chemotherapy and face a dire prognosis. There is a sorely unmet need to develop more effective immunotherapy to improve AML therapy. Our proposed studies to develop the nanobody-directed, bispecific and inducible CAR T approach aims to establish a novel and safe CART system to cure AML.